Investigating mitochondrial networks as a critical determinant of response to antibody drug conjugates in advanced NSCLC

Project Summary
The goal of this study is to evaluate mitochondrial networks as a critical determinant of response to antibody
drug conjugates (ADCs) in advanced/metastatic (adv/met) non-small cell lung cancer (NSCLC). Recent
advances with immune checkpoint inhibitors and targeted therapy have revolutionized the treatment of adv/met
NSCLC, but most patients eventually develop therapy resistance. As such, novel approaches to the management
of adv/met NSCLC are emerging, including three promising ADCs with the topoisomerase I (topo I) payload
deruxtecan (DXd) that target HER2 (T-DXd), HER3 (HER3-DXd), and TROP2 (Dato-DXd). Importantly, recent
data suggest that these three DXd-ADCs are effective in adv/met NSCLC after failure of standard therapies.
Upon target receptor binding (HER2/HER3/TROP2), DXd-ADCs are internalized via receptor-mediated
endocytosis, leading to cleavage of a plasma stable linker, selective delivery of the DXd payload, and DXd
mediated tumor cell apoptosis. As such, it would be predicted that the efficacy of DXd-ADCs would be reliant
upon high tumor target receptor expression assessed by IHC and expressed as an H-score. However, published
data suggest that H-scores are unreliable predictors of patient response to DXd-ADCs and no clear
understanding of the biological principles underlying NSCLC tumor response to these emerging agents exists.
Apoptosis is the cytotoxic endpoint of the DXd payload, a process that is governed by mitochondria, and our
preliminary data, generated via the novel structural/functional analysis that integrates positron emission
tomography (PET) imaging with ultra-resolution microscopy, suggest that the structure and function of
mitochondrial networks is mechanistically linked to DXd-ADC induced apoptosis. As such, we hypothesize that
tumor intrinsic mitochondrial network structure and function dictate response/resistance to DXd-ADCs in NSCLC.
To test this, Aim 1 will investigate baseline mitochondrial network architecture as a critical determinant of DXd-
ADC response in NSCLC by profiling mitochondrial networks and cristae in cell lines, xenografts, patient-derived
xenografts (PDXs), and tumor samples from DXd-ADC treated patients. In Aim 2, we will investigate
mitochondrial network remodeling as a critical mechanism of DXd-ADC adaptive resistance, by quantitatively
measuring changes in mitochondrial networks in cell lines, xenografts, PDXs, and primary patient tumors as
DXd-ADC resistance occurs. Since most NSCLC patients do not respond to DXd-ADCs, quantitative profiling of
mitochondrial networks has the potential to improve DXd-ADC patient outcomes by identifying conserved
biological principles underlying treatment response.

Public health relevance
Project Narrative Lung cancer is the leading cause of cancer-related mortality in the United States and will claim the lives of approximately 125,000 Americans in 2024. As such, novel approaches to the management of non-small cell lung cancer (NSCLC) are emerging, including several antibody drug conjugates (ADCs) that selectively deliver cytotoxic chemotherapy payloads directly to tumors. The goal of this study is to utilize longitudinal mitochondrial network profiling to improve patient outcomes with ADCs by identifying conserved biological principles underlying treatment response and resistance.